Functions of a novel suppressor of oncogenic Ras

Functions of a novel suppressor of oncogenic Ras
Oncogenic Ras accounts for more than 30% of all human cancers. Ras normally controls mitogenic pathways
and functions as an on/off switch controlling cell proliferation. Heterochromatin appears to be a form of cellular
restraint in both flies and humans that oncogenic Ras has to overcome to induce cell proliferation. Many tumor
suppressors, such as Rb and BRCAs, play a role in heterochromatin formation, and an inability to form
heterochromatin formation itself permits tumorigenesis in response to oncogenic Ras. However, how
heterochromatin formation counteracts oncogenic Ras and how Ras can overcome heterochromatin-mediated
tumor suppression remain unclear. Understanding how heterochromatin counteracts oncogenic signals and
how oncogenic pathways overcome heterochromatin to induce growth and proliferation may lead to novel
epigenetic cancer therapeutics.
To investigate the connection from oncogenic mutations to epigenetic alterations, we have used Drosophila
genetics to identify new players mediating cellular responses to oncogenic Ras, with a particular attention to
nonconventional Ras signaling components. Among the novel suppressors of oncogenic Ras, we found that
CRIF regulates both cell proliferation and heterochromatin formation. The objective of this project is to
understand the mechanism by which the putative tumor suppressor CRIF antagonizes the effects of oncogenic
Ras on cell proliferation. The long-term goal of the research is to elucidate how heterochromatin formation
functions in epigenetic tumor suppression and how oncoproteins reorganize chromatin to induce cell
proliferation and tumorigenesis. We hypothesize that CRIF counteracts oncogenic Ras by inhibiting cell
proliferation and increasing heterochromatin formation, an epigenetic tumor suppression system. In this
proposal, we plan to elucidate the molecular functions CRIF in counteracting oncogenic Ras-induced
proliferation and in heterochromatin regulation. Specifically, we will investigate how CRIF resist oncogenic Ras
in controlling proliferation, and the role of CRIF in regulating heterochromatin. Results from these studies will
break new grounds for investigating the molecular mechanisms underlying the epigenetic effects of oncogenic
Ras, the role of epigenetic dysregulation in cancer development, and the role heterochromatin in tumor
suppression.

Public health relevance
Project Narrative Epigenetic alterations including heterochromatin changes are important for cancer development as well as tumor suppression, but the mechanisms remain unclear. The current project focuses on a novel suppressor of Ras, CRIF, which may provide an inroad leading to understanding how oncogenic Ras reorganizes chromatin to induce cell proliferation and how heterochromatin formation functions in epigenetic tumor suppression. Understanding how CRIF regulates heterochromatin and counteracts oncogenic signals to resist tumorigenesis may lead to novel epigenetic cancer therapeutics.